Anion Abstraction From Hypervalent Silanes: Enantioselective Synthesis of Compounds Bearing Carbon and Silicon Stereogenic Centers

Project Summary
The incorporation of chiral, stereogenic centers in small molecule drug candidates is statistically linked to
success in clinical trials. In order to design more structurally complex bioactive compounds, chemists must rely
on efficient synthetic tools. The objective of this proposal is to develop novel modes of reactivity that deliver
molecules containing carbon and silicon chiral, stereogenic centers inaccessible through existing methods.
Specifically, this proposal outlines a novel application of asymmetric ion-pairing catalysis to hypervalent silicate
/ chloride ion pairs, engaging hypervalent chlorosilanes with dual hydrogen-bond donor catalysts via an anion-
binding mechanism. Mechanistic studies of hypervalent chlorosilanes have established that ionization of the
silicon-chloride bond is relevant to many transformations involving organosilanes in the presence of nucleophilic
or Lewis basic additives. Despite this evidence, these reactive ion pairs have not been used as handles in the
design of asymmetric transformations. Using dual hydrogen-bond donors to catalyze anion binding from
hypervalent silicon will be explored in two orthogonal approaches based on shared mechanistic principles. The
first approach establishes Lewis acid / hydrogen-bond donor co-catalysis utilizing cationic hypervalent silicates
as highly electrophilic Lewis acid catalysts through the design of a tailored bifunctional hydrogen-bond donor
catalyst. This cooperative catalytic approach will be applied to an asymmetric Passerini two-component reaction
(P-2CR), generating alpha-hydroxy amides, prominent motifs in bioactive molecules. Asymmetric induction
through cooperative non-covalent interactions between the silicate-electrophile / chloride-catalyst ion pair is
expected to result in high enantioselectivities across a wide substrate scope. If successful, this approach to
Lewis acid / HBD co-catalysis provides a new and potentially general approach to enantioselective additions to
carbonyl compounds. The second application will apply anion-binding catalysis to the enantioselective synthesis
of silicon-stereogenic alkoxyorganosilanes. Few catalytic methods exist to access enantioenriched
alkoxyorganosilanes, which have significant, yet underexplored, roles in drug discovery. Kinetic studies and
computational evaluation of putative reactive intermediates will help build a comprehensive mechanistic
understanding of these reactions, guiding further application of this novel anion-binding approach to additional
transformations. It is expected that these methods will aid chemists in the design and synthesis of small molecule
drugs and tool compounds that positively impact human health.

Public health relevance
Project Narrative The design of small molecule drug candidates with well-defined three-dimensional properties has been directly correlated to their clinical success. This proposal describes a novel application of asymmetric ion pairing catalysis to the synthesis of compounds bearing carbon and silicon stereogenic centers that are largely inaccessible using existing methods. As the construction of complex small molecules is a limiting factor in drug discovery, the proposed research will assist scientists in the development of molecular tools and therapeutics to understand and treat human health.